CSHL 2025 Neurobiology of Drosophila Conference

This proposal requests support for a unique international meeting, the biennial Neurobiology of Drosophila conference at Cold Spring Harbor, to be held in 2025, the 21st meeting in this series. For the 2025 edition, the organizers have focused the meeting on topics of direct bearing on the central goals of the NIH Neuroscience Blueprint and BRAIN initiative; it supports the mission of NINDS and also those of NICHD, NIDA, NIAAA, NIA, NIMH, and NIAID. The meeting will explore the latest advances being made in the highly successful model system of the fruit fly Drosophila melanogaster through the combined power of genetics, molecular biology, cell biology, electrophysiology, imaging, connectome, and behavioral analysis to address fundamental issues in neurobiology with direct relevance to human health and disease. The meeting will have nine oral sessions:1) Nervous System Evolution: Brain and Behavior; 2) Nervous System Disease and Injury Models 3) Technological Advances; 4) Connectome and Behavior; 5) Cell Biology of Neurons and Glia; 6) Diversity - from Cells to Individuals; 7) Circuit Construction and Remodeling; 8) Neuromodulation and Plasticity; and 9) Sensory Systems and Brain-body Interactions. There will be three poster sessions presenting work drawn from each of these areas and career development sessions on guidance for navigating careers in academia and alternate career trajectories. Finally, there will also be two special plenary presentations: the keynote Benzer Memorial Lecture and the Elkins Memorial Lecture, an honor awarded to the student who has written the best Ph.D. thesis since the previous meeting. The 2025 Benzer Memorial Lecture will be given by Dr. Scott Waddell (Oxford University), whose pioneering work has shed light on molecular and circuit mechanisms of learning and memory. The meeting will remain of moderate size (~450 participants) to facilitate in-person discussion, exchange of ideas and techniques, and promote new collaborations in rapidly evolving fields. In addition, virtual participation will be available to include those who cannot come in person. Roughly half the attendees have previously attended the meeting, highlighting its importance and relevance, and the new attendees bring fresh ideas and extend the meeting's reach. All applicants will be encouraged to submit an abstract; historically, over 75% present a talk or poster. Session leaders and meeting organizers will choose speakers from the most timely and interesting abstracts submitted a few months in advance of the conference; this ensures that late-breaking science is covered in all talks. This meeting has always attracted investigators across many career stages and has an excellent record of promoting young investigators' scientific development; most speakers are trainees. Special attention will be paid to running an energetic, and welcoming meeting that shares new findings and technological developments at the forefront of the rapidly moving and influential field of Drosophila neurobiology.

Public health relevance
NEUROBIOLOGY OF DROSOPHILA MEETING COLD SPRING HARBOR LABORATORY October 7 – 11, 2025 Project Narrative This Neurobiology of Drosophila conference focuses on the pioneering advances that can be made using the combined power of genetics, molecular biology, biochemistry, cell biology, electrophysiology, imaging, and behavioral analysis to address fundamental issues in neurobiology in vivo using the model organism Drosophila melanogaster. Building on one hundred years of research, the fly neurobiology field is burgeoning, with hundreds of laboratories worldwide making these significant advances and playing a key role in developing trainees. A driving principle is that the fruit fly while seeming to have little in common with humans, shares many of the same genes, molecules, and neural wiring — albeit far simpler — with vertebrate animals. Understanding how neurons and circuits develop and work using Drosophila has led the way to providing insights and approaches and developing tools that can be adapted to elucidate nervous system function in higher animals. In this way, the field significantly impacts thinking about neurological disease, brain evolution, circuit mechanisms underlying complex behavior, and other major themes of human biology. The overarching aim of this conference is to provide a forum to bring together a diverse group of scientists working in different areas to advance the impact of fly neurobiology. The meeting will be of moderate size (~450 participants); it will have no parallel sessions to facilitate discussion across disciplines, the broad exchange of ideas and techniques, and the promotion of new collaborations in this rapidly evolving field. The previous meeting participants have chosen the 2025 scientific organizers to ensure a fresh perspective. These organizers are directing the upcoming meeting on topics and themes of direct relevance to the primary mission of the National Institutes of Health, particularly the goals of the NIH Neuroscience Blueprint and NIH BRAIN initiative. All applicants are encouraged to submit an abstract, focusing on new and unpublished work, and the large majority of participants will present a talk or poster. All speakers, except one keynote and one student prize lecture, will be selected from these abstracts, and they will principally be postdocs and trainees. They will be chosen by session chairs, who are emerging global leaders in their respective fields, and under the guidance of meeting organizers who can tailor to provide balance and diversity. We will choose the most timely and interesting abstracts submitted a few months in advance of the conference, ensuring that late-breaking science is covered in all talks.